Essential functions of Trypanosoma brucei RAP1

Project summary
Trypanosoma brucei causes human sleeping sickness and sequentially expresses immunologically distinct
Variant Surface Glycoproteins (VSGs), its major surface antigen, to evade the host’s immune response and
establish a long-term infection. VSG is transcribed one at a time (in a monoallelic manner) from regions next to
the chromosome end termed telomere. Parasites that express more than one type of VSG are more quickly
eliminated by the host. Therefore, monoallelic expression (MAE) of VSG genes is critical for parasite survival.
We have shown that T. brucei RAP1, a telomere protein, is essential for telomere integrity, hence parasite
proliferation, and VSG MAE. In order for RAP1 to execute these roles, its ability to bind dsDNA is essential but
not sufficient. We hypothesize that a high concentration of telomere-localized RAP1 is required. Since RAP1
interacts with TRF that specifically binds the telomeric DNA, we hypothesize that this interaction helps enrich
RAP1 at the telomere. We will test this by examining RAP1 chromatin association profile in WT and RAP1
mutants defective of RAP1-TRF interaction or DNA binding. VSG MAE has two key aspects: silencing all but
one VSG genes in the T. brucei genome and sustaining high-level expression of the only active VSG, both
depending on RAP1. On one hand, RAP1 helps compact the telomeric chromatin, which is critical for VSG
silencing, but the underlying mechanisms are unknown. We found that RAP1 is essential for normal level
expression of H3v, a histone variant enriched at the telomere and important for complete VSG silencing. RAP1
also interacts with FYRP, a subunit of the chromatin remodeler ISWI that is important for VSG silencing.
Therefore, we hypothesize that the RAP1-H3v/FYRP interactions play important roles in RAP1-mediated VSG
silencing. We will determine the interfaces of these interactions and examine VSG silencing status in RAP1
mutants defective of these interactions. On the other hand, we found that unlike vertebrate and yeast RAP1
homologs, T. brucei RAP1 has an RRM domain that mediates its binding to the active VSG RNA in vivo.
Intriguingly, RAP1’s RNA and DNA binding activities compete with each other in a substrate concentration-
dependent manner. At the active VSG locus, RAP1’s binding to the highly concentrated active VSG RNA
effectively blocks its binding to local dsDNA and disrupts the RAP1-mediated silencing, enabling high-level
expression of the active VSG. However, exactly what RNA sequences can be recognized by RAP1 and how
RAP1 specifically regulates VSG MAE is unknown. We will characterize the properties of RAP1’s RNA binding
activity using both in vivo iCLIP approach and several in vitro approaches including gel shift, NMR titration,
RNA toeprinting and RNase footprinting. Our studies on RAP1 helps build a comprehensive view of RAP1’s
pleiotropic functions and will venture into a new paradigm for better understanding mechanisms of antigenic
variation in T. brucei. Investigating essential activities uniquely found in kinetoplastid RAP1 homologs will also
benefit development of better treatments of infections caused by kinetoplastid parasites including T. brucei.

Public health relevance
Project Narrative Treatments are limited for infections of Trypanosoma brucei, which sequentially expresses different variant surface glycoproteins (VSGs, its major surface antigen) in a strictly monoallelic manner to evade the host’s immune response. We have found that RAP1 silences all but one VSG genes and suppresses VSG switching. In this proposal, we will investigate how RAP1’s novel nucleic acids binding activities and its interactions with other telomeric proteins, histones, and chromatin remodelers contribute to monoallelic VSG expression and proper antigenic variation.